Mechanisms of extracellular vesicle biogenesis that regulate wound healing

SUMMARY
Resolution in skin wound healing is coordinated by intercellular communication processes that
include extracellular vesicles (EVs) containing biologically active protein and nucleic acid. In injury
models, EVs have been shown to be important mediators of tissue repair, although the
mechanisms underlying the formation of specific EV subsets, loading of EV payloads, and cell-
type specific EV uptake remain poorly understood. We address this knowledge gap with a
comprehensive genetic approach to modify the regulation of EV biogenesis to change the EV
Profile, Payload and Activity in cutaneous wound models that have well-defined biological
relevance. We have recently established that genetic tools regulating EV biogenesis `re-program'
EV payload. Moreover, over-expression of specific pro-reparative payloads that were identified
by mass spectrometry can be engineered and delivered to promote resolution in models of
impaired wound healing. With a focus on the discovery of novel EV mediators of crosstalk
between immune and epithelial cells in the wound bed, we have focused on the biology of EVs in
mediating intercellular signaling in EVs formation (Project 1-EV Biogenesis), the engineering of
biologically active payloads (Project 2-EV Payloads), and identifying specific cell types that
internalize EVs in the wound bed (Project 3-EV Uptake). Together, these Projects address the
over-arching goals of creating therapeutic EVs with a systematic approach that is optimized for
specific cell types based on an understanding of 1) How and where EVs are made?; 2) How EVs
are loaded and whether they are biologically active ?; and 3) Which cells uptake EVs to promote
durable tissue repair.

Public health relevance
Narrative The proposed studies focus on small extracellular vesicles secreted by wound macrophages in sites of injury that regulate stromal cells by suppressing the inflammation phase to promote re- epithelialization. We hypothesize that a mechanistic understanding of how small extracellular vesicles are formed, what contents are biologically active, and which cells uptake these vesicles is critical for the over-arching goal of developing extracellular vesicles that have therapeutic potential by promoting the resolution of inflammation and wound closure.